Great Plains IDeA-Clinical and Translational Research Network, Urgent Competitive Revisions to IDeA and NARCH Programs for SARS-CoV-2 Surveillance Studies

Project Summary:
This application from the Great Plains IDeA Clinical and Translational Research (GP IDeA-CTR)
network responds to NIGMS call (NOT-GM-22-026) for Urgent Competitive Revisions to IDeA Programs for
SARS-CoV-2 Surveillance Studies. Our innovative approach addresses three specific aims (SA): SA1 Unites
the UNMC SPHERES (CDC SARS-CoV-2 Sequencing for Public Health Emergency Response, Epidemiology,
and Surveillance) team, Nebraska Medicine (NM) clinical enterprise, and the Nebraska Public Health
Laboratory (NPHL), to develop, standardize, validate, and deploy the infrastructure and communication
protocols for integrating real-time viral variant data within CRANE (Clinical Research Analytics Environment).
CRANE is a research data warehouse extracted from the NM EHR system, comprising over 1.4 million
individuals, including 29,000 SARS-CoV-2 infected persons and 2,000 with variant data available for
immediate linkage. SA2 Creates a Consortium to Organize Research in Nebraska for Covid 19 (CORN-19),
spanning public health experts, clinician-scientists, and informaticists, strengthening the discovery pipeline
from bench to bedside to policy. SA3 Profile the SARS-CoV-2 variant landscape in Nebraska by geographic
region, risk profiles, and social determinants of health.
This project deploys, leverages, integrates, and benefits from several powerful UNMC capabilities.
UNMC hosts one of the most productive US infectious disease units, closely linked with state and national
surveillance networks; is a site in the CDC’s SPHERES program; holds the largest US biocontainment unit;
provides SARS-CoV-2 whole-genome sequencing support and variant tracking across NE with strong ties to
the NPHL; and maintains the CRANE data warehouse. We deploy these powerful capabilities to test
hypothetical links between COVID-19 illness (acute and chronic), post-vaccination infection, and community
susceptibly with specific SARS-CoV-2 mutations and lineages, in line with five NOT-GM-21-031 priorities
areas: 1) Variants in the population and how cases caused by different variants change over time? 2) Are
cases of infection by different variants associated with outbreak events, geographic locations, or specific
times? 3) How are different variants distributed among different racial, ethnical, gender, or age groups? 4) Are
specific variants associated with different COVID-19 symptoms? 5) Are specific variants associated with more
frequent vaccine breakthroughs. Real-time health surveillance data linked to EHR data expands the possibility
of a learning healthcare system in which actionable evidence improves health care and saves lives across our
communities, particularly in medically underserved and rural areas. As a result of this integrative silo-
spanning project, we expect to provide a robust, scalable, egalitarian framework for community-engaged
CTR – a national model for addressing urgent biomedical research needs that outlasts the current pandemic
and promises a springboard toward future academic-public-private partnerships to serve our region better.

Public health relevance
Project Narrative: The proposed project will provide a model for implementing surveillance SARS-CoV-2 variant data linked with clinical data within a research data warehouse to study variant evolution and spread in Nebraska. We seek to evaluate the differences in COVID-19 clinical outcomes relative to the variant infecting agent, focusing on the impact on underserved and rural populations. This project will harness person-level variant information linked to EHR data to create a rich resource for genomic epidemiology to address five of the priority areas described in NOT-GM-22-026.